Regulatory elements of replication timing and 3D genome organization

PROJECT SUMMARY
Increasing evidence indicates that 3D genome architecture is required to regulate gene function and its
alterations are associated with many diseases. The genome is organized into compartments that align
with the temporal order of DNA replication (replication timing – RT). However, little is known about the
mechanisms underlying RT control and 3D genome organization. Recently, we identified a novel class
of cis regulatory elements that control RT and 3D genome organization: early replicating control
elements – ERCEs. Our long-term goals are to study what are the regulatory elements of genome
organization in human differentiated cell types, investigate how trans-acting factors control these
elements, and define how 3D genome organization is remodeled during development and evolution. To
achieve these goals, we are deleting and inserting candidate ERCEs into the genome of human
differentiated cell types and testing their effects on RT, 3D genome organization and gene expression.
We are also exploiting highly synchronous human embryonic stem cells differentiation systems to track
ERCE activation during cell fate commitment. Finally, to better understand how the genome was
remodeled during evolution, we are performing comparative analyses of 3D genome organization and
function using primary cells derived from different species. Overall, we expect that our work will
contribute significantly to understand the fundamental principles of genome organization and its
relationship to gene function.

Public health relevance
PROJECT NARRATIVE Organization of the human genome in the nucleus is critical to maintain proper gene function and its alterations are linked to disease. However, little is known about the mechanisms underlying 3D genome organization. This study is important to public health because it will identify the regulatory elements that control genome organization and contribute to understand the significance of genome organization alterations in disease.